A metabolomics-based laboratory developed test to improve the diagnostic precision of Polycystic Ovary Syndrome

Abstract
Polycystic ovary syndrome (PCOS) is a complex, multifactorial endocrine disorder characterized by
hyperandrogenism, chronic anovulation, and polycystic ovaries. It is currently diagnosed by the Rotterdam
criteria, which categorizes the presentation of these basic symptomologies into four main phenotypes labeled A,
B, C, and D. While these phenotypes can define disease and inform clinical decision making in a broad sense,
our ability to select the best precision treatments and appropriate cohorts for clinical trials remains limited
because there is considerable heterogeneity within phenotypes and little data by which to define them with higher
precision. Defining PCOS phenotypes with higher precision to thereby improve patient outcomes starts by
incorporating additional, evidence-based diagnostic criteria into present day diagnostic guidelines.
In this Phase I SBIR, we will address the need for greater precision by testing the hypothesis that using
metabolomics data in conjunction with clinical symptoms can define PCOS phenotypes with higher precision
than clinical symptoms alone.
Metabolites are the small molecule intermediates and products of metabolism upon which the inputs from the
genome, the environment, and lifestyle factors converge. Given their unique position in the central dogma of
biology they are considered to be the closest reflection of an individual’s real-time health status. Metabolites
reflect disease activity through changes in their abundance, which can be quantified using ultra-high performance
liquid chromatography and tandem mass spectrometry (UHPLC-MS/MS). When used in an untargeted manner,
UPLC-MS/MS can measure the entire collection of metabolites in a given biological sample (the metabolome),
enabling broad screening of an individual’s biochemical profile to identify disease-causing metabolic
perturbations (metabolic signatures of disease). We and others have shown that metabolic signatures associated
with PCOS can provide deep phenotypic insight into disease activity. In collaboration with Dr. Richard Legro at
Penn State Medical School, Metabolon will leverage its proprietary UHPLC-MS/MS platform, NGPTM, to
interrogate metabolic signatures unique to PCOS phenotype A and phenotype B and utilize high level statistical
analyses to determine whether metabolic profiling can identify novel, clinically relevant sub-phenotypes and
thereby define phenotypes more precisely than clinical symptoms alone.
In success, the findings of this project will justify a follow-up study in which we develop a diagnostic test that
targets these phenotype-defining metabolic signatures. The ultimate outcome of a successful Phase I will be the
development of a tool that allows PCOS phenotypes to be defined more precisely than today’s diagnostic
guidelines, which represents a step towards improving clinical decision making, patient stratification in clinical
trials, and overall patient outcomes.

Public health relevance
NARRATIVE The goal of this project is to test the hypothesis that metabolomics data used in conjunction with clinical symptoms can reveal novel and clinically relevant sub-phenotypes of polycystic ovary syndrome (PCOS). We will use Metabolon’s proprietary mass spectrometry platform to interrogate global metabolic profiles of serum collected from patients diagnosed with either PCOS phenotype A or phenotype B. We will then evaluate biomarker clustering using Random Forest Analysis to determine if metabolomics data can reveal novel phenotypes and thereby improve the precision of diagnostic classification.